MOLECULAR MECHANISMS OF INTESTINAL TRANSPORT

The long-term objective is to understand solute transport across the intestinal epithelium. Particular emphasis will be placed on Na and glucose absorption during this phase of the project. The starting point is the recent cloning and functional expression of the brush border Na/glucose cotransporter in Xenopus oocytes. The specific aims are as follows: 1) to describe the kinetics of Na/glucose cotransport. This will be accomplished by expression the transporter in Xenopus oocytes or COS 7 cells, and measuring 22Na and 14C-sugar fluxes, and sugar- dependent in ward Na currents. Fluxes and currents will be measured as a function of membrane voltage and extra- and intracellular substrate concentrations. 2) determine whether homology exists between the intestinal Na/glucose cotransporter and other cotransporters in the intestine and kidney. This will be accomplished by Northern and Western blots and the screening of cDNA libraries. 3) describe the expression of the Na/glucose contransporter as the immature enterocyte migrates from crypt to villus tip. Expression will be followed by in situ hybridization and immunocytochemical techniques, and processing of the protein from the endoplasmic reticulum to brush border membrane will be charted by Western blots of subcellular fractions. Changes in expression will be examined during development and with dietary and humoral status of the animal. Finally, we will attempt to determine the locus of the genetic defect in patients with glucose-galactose malabsorption syndrome.